The Role of Early Life Stress in Feeding Behaviors

Neurodevelopmental disorders (NDD) affect the development of the nervous system, leading to abnormal
brain function which may affect emotion and self-control. Obesity is an important co-morbidity of NDDs and
are thought to arise from the impairment of important feeding-relevant circuits. Early life stress (ELS) can
remodel feeding relevant circuits and contribute to obesity, yet the underlying mechanisms driving these
changes are unknown. The current project aims to provide a link between early life stress and obesity. Our
preliminary data show that in adult rodents, chemogenetic inhibition of neurotensin-expressing neurons in
the lateral septum (LSNTS) increases standard chow intake. When exposed to HFD, silencing of LSNTS
neurons increase HFD intake and accelerates obesity. Interestingly, LSNTS neurons respond to stressful but
also to rewarding stimuli (i.e. HFD) and are key to the brain circuitry regulating feeding behavior.
Additionally, ELS has been shown to alter neuronal activity in the LS and affect motivated behaviors, such
as social interaction. We will extend these preliminary data to test the hypothesis that ELS reprograms
LSNTS neurons activity downregulating important molecular pathways, ultimately impacting feeding
behavior. In Aim 1, we will employ in vivo calcium imaging to monitor changes in the activity of LSNTS
neurons to better understand how ELS alters LSNTS neuronal encoding of rewarding information and how
these changes impact binge eating behavior and HFD consumption. In Aim 2, we will use cell type-specific
molecular profiling (viralTRAP) and next-generation sequencing to molecularly profile LSNTS neurons in ELS
and control mice to assess which specific gene transcripts are altered by ELS. Together, our study will
clarify how ELS contributes to obesity by affecting feeding-relevant specific circuits in the brain. The project
will benefit from the CNDD cores for behavioral assays, in vivo imaging, bioinformatics approaches, and
advanced biostatistical consulting. The career development and mentorship will help the PI obtain future
NIH R01 funding to facilitate the transition to an established investigator in the field of
neurodevelopment and its disorders.